Limiting Dysglycemia Around Physical Activity for People with Type 1 Diabetes Using Activity-Aware Automated Insulin Delivery – the APEX Project.

In this project we aim to transform glycemic control during physical activity (PA) among persons with Type
1 diabetes (PwD) by testing three novel complementary approaches toward adjusting insulin delivery
before, during, and after PA. The vision behind these approaches is based on the importance of PA for
myriad health considerations among PwD—and the reluctance among some to exercise because of fear
of hypoglycemia or the need to plan and manage insulin requirements around PA. The approaches we will
test each employ separate ways to adjust insulin delivery related to PA: 1) accounting for real-time
changes in insulin sensitivity following PA, 2) the amount of “activity-on-board,” which acknowledges the
ongoing influence of prior activity on future insulin needs, and 3) anticipated future activity based on past
PA patterns. These studies are particularly valuable given the long track-record of the UVa Center for
Diabetes Technology (CDT) in both T1D-related engineering innovations and in the CDT’s ability to test
novel developments using well-designed clinical trials.
It is important to note that all of the studies in this proposal are assessed in the context of the UVA fully-
closed loop (FCL) automated insulin delivery system (AID), called APEX, meaning that these new
approaches are meant to be incorporated into an AID system in which PwD will not need to announce
carbohydrate intake or PA—allowing for a more spontaneous life. Each of the approaches to improving
glycemia in the setting of PA is implemented as an algorithmic module added to the APEX FCL controller—
and the safety and efficacy of each of the modules is compared to APEX without the given algorithmic
module in a randomized, double-blinded, cross-over fashion, allowing direct comparison of the added
benefit of each individual module.
In Aim 1 of this proposal, we hypothesize that continuously tracking insulin sensitivity and “activity-on-
board” (tested separately) and informing the APEX system of these construct to modulate insulin delivery
during and after PA will improve glycemia via reduction of the Low Blood Glucose Index (LBGI) compared
to APEX alone. Aim 2 will test the hypothesis that an automated system can detect daily patterns of PA
and that these patterns can be anticipated by the APEX controller, for example by reducing insulin prior
to a likely PA, and improve glycemia (again with LBGI as primary outcome). The trials in both Aims 1&2
will be in a hotel setting with supervised exercise sessions. Aim 3 then focuses on the deployment of the
PA-informed APEX system at home during a randomized, cross-over study with 3-week sessions and usual
home PA design to confirm the superiority of the exercise-informed AID.
These studies will advance T1D management by rigorously testing novel means of glucose management
in the setting of PA—with the overall goal of making exercise safer and more feasible for PwD.

Public health relevance
This project proposes to advance the opportunities for safe physical activity among people with Type 1 diabetes (T1D) by testing the efficacy three new promising approaches in a controlled setting—and then validating the resulting device in a real-world setting at home. The approaches will adjust insulin delivery in response to 1) real-time changes in insulin sensitivity, 2) the amount of “activity on board,” which acknowledges the influence of prior activity on future insulin needs, and 3) anticipated future physical activity based on past physical activity patterns. All of these will be tested as added modules in a fully- automated closed loop system (with resultant glycemia compared to the system without the modules) with a vision of providing the safe ability for physical activity in T1D without added user action.